Refinement of the Comprehensive Mobile Assessment of Pressure (CMAP) System for Prevention of Pressure Injuries

Objectives: The long-term goal of this project is to improve the effectiveness of pressure injury prevention
education by clinicians and self-management by Veterans with spinal cord injury (SCI) through a methodical
development and testing of a mobile platform based pressure mapping system called “Comprehensive Mobile
Assessment of Pressure” (CMAP). The targeted risk-reduction behavior in this project is the effective use of
weight shifts when sitting in a wheelchair by improving consistency, frequency, duration, and quality of
movements to redistribute pressure. CMAP provides visual cues as well as individually customizable reminders
that are designed to compensate for the lack of sensation that prevents the use of natural cues to redistribute
pressure, by wheelchair users. An updated CMAP system will serve two important objectives: 1) assist clinicians
in assessment, individualized goal-setting, and monitoring the Veteran with SCI’s progress toward pressure
injury prevention behavior goals while in the hospital setting; and 2) assist clinicians with individualized setup
and education of the Veteran with SCI for using the CMAP system in the home setting as a self-management
strategy for pressure injury prevention.
Specific Aims: The specific aims of this study include: 1a) hardware expansion to improve functionality of the
CMAP system to add a docking and charging station and use of CMAP on a smartwatch based on Veteran
preferences and 1b) software expansion to enhance clinical education for pressure injury prevention education,
with requirements provided by clinicians; 2) determine usability of the refined CMAP system when it is integrated
into patient education for Veteran’s with acute SCI during their inpatient rehabilitation stay, and 3) a determine
usability and efficacy of the refined CMAP system for clinician-delivered pressure injury prevention education,
followed by Veteran use of CMAP in their daily routines at home.
Study Design: This four-year study will have multiple stages and will use a mixed methods approach that includes
iterative focus groups and interviews with Veterans who have SCI and with clinicians who provide pressure injury
prevention education to Veterans with SCI; self-efficacy and usability surveys for both Veterans and clinicians;
pilot testing of CMAP during inpatient rehabilitation and testing during outpatient visits. Repeated measures will
be used to evaluate changes within subject for completion of weight shifts while using CMAP, compared to
periods when not using CMAP.
Methods: During the first two years, improvements to CMAP hardware and software will be guided by experience-
based design guided requirements learned about through iterative focus groups including Veterans with SCI/D
(n=10) and clinicians (n=10). Usability will be measured at each iteration of development using the System
Usability Scale (SUS) and the User Experience Questionnaire (UEQ). The focus groups will be repeated to
ensure alignment between development progress and the requirements identified by the focus groups. During
the inpatient pilot test, clinician (n=3) and Veteran (n=6) self-efficacy will be measured. Veterans will complete
selected sub-scales from the Skin Care Belief Scale and clinicians will answer survey questions developed
specifically around providing education for performing weight shifts effectively. Veteran progress toward weight
shift goals will be measured through performance monitoring within the CMAP app; Actual performance will be
assessed against the individualized goals set by the clinician. During the outpatient testing, Veterans (n=20) will
use CMAP at home for 2 weeks after receiving education and individualized goals for weight shift performance
by clinicians. While at home, trunk movements will be monitored via actigraphy to monitor weight shift frequency
to compare to baseline trunk movement data, weight shift performance data within CMAP app, and finally,
compared with individualized goals for performing weight shifts. Self efficacy and usability (SUS and UEQ) of
the overall system in both settings will be measured.

Public health relevance
For Veterans with spinal cord injury who use a wheelchair, pressure injuries related to sitting are a significant daily threat to well-being. Pressure injuries are costly to treat, negatively impact quality of life and community participation, and can be life threatening. Moving or shifting at regular intervals in the wheelchair redistributes harmful pressure and reduce risk for skin breakdown, yet these movements are a challenge to perform consistently. The challenge exists due to lack of sensation to let the individual know they need to shift their weight. Pressure mapping provides a detailed visual representation of pressure distribution and can compensate for impaired sensation. Pressure mapping feedback delivered on-demand on mobile platforms can potentially increase effectiveness in carrying out behaviors to reduce risk for pressure injury when used during clinician-delivered education to set goals and monitor progress and when used at home as a self- management strategy.